Computational Framework to Enhance Antenna-based Electromagnetic Imaging

Project Summary
Electromagnetic (EM) imaging has demonstrated significant potential to become a powerful medical imaging
technology. Developments in microwave, millimeter-wave, and radio-frequency technology over the last few
decades have demonstrated applications in fields such as brain stroke identification and stroke-type
differentiation, breast cancer detection, bladder state tracking, and osteoporosis monitoring, among others. EM
imaging’s key advantages include deep tissue imaging, non-ionizing radiation, and cost-effective/portable form
factors. Unfortunately, EM imaging suffers from two key disadvantages that limit its clinical utility: 1) traditional
reconstruction models cannot efficiently account for microwave scattering in complex and heterogeneous
biological tissues; and 2) current state-of-the-art antenna arrays are limited by the physical size of individual
antenna elements, which do not allow measurements to be densely or optimally captured around an object. This
drastically reduces imaging resolution, and can prevent accurate visualization of lesion size and shape. This
proposal develops a new EM imaging paradigm where measurements can be collected from a set of
optimized antenna locations to drastically enhance 3D EM imaging capabilities. Our proposed project will
include two major components: 1) computational frameworks will be formulated to reconstruct 3D
permittivity from noninvasive microwave scattering measurements. These frameworks will leverage recent
advances in big-data computing, and will utilize optimization-based and machine-learning tools to model
microwave scattering through biological tissue; and 2) specialized antenna arrays will be developed to collect
microwave scattering measurements, with individual antenna elements positioned at either ultra-high
densities or optimized non-regular spacings. The antenna spacings in the non-regular spaced array will be
computed based on identifying antenna-positions within the ultra-high-density array that have a greater effect
than others on 3D permittivity reconstruction. Identifying these positions will enable 3D permittivity to be
accurately reconstructed with fewer measurements and less reconstruction time. The utility of this new approach
will be demonstrated through application-oriented testing in the context of both imaging of the head to
differentiate stroke-type and of the breast to detect and monitor cancer. In this proposal, the test-case is on using
microwaves to reconstruct 3D dielectric permittivity (which is an indicator for tissue water content, and is modified
by disease state), but this paradigm can readily be extended to other regions of the electromagnetic spectrum.
Overall, this project will enable the high resolution imaging with accurate localization of lesion size and shape
that is pivotal for successful clinical translation of EM imaging. The outcomes of this project will be applicable to
the diverse clinical applications of EM imaging, spanning from cancer detection, personalized treatment progress
monitoring, quantification of inflammation, to real-time tracking of thermal therapies.

Public health relevance
Project Narrative The proposed project will develop a new paradigm for electromagnetic (EM) imaging that enables visualization with drastically higher resolution than currently possible with conventional antenna arrays. Combined with EM imaging’s naturally non-ionizing radiation, deep-tissue imaging capabilities, and low-cost/portable form-factor, this development will enable EM imaging to become a main workhorse for medical imaging and monitoring. With applications in cancer detection and personalized treatment progress monitoring, quantification of inflammation and healing, and real-time tracking of thermal therapies, the outcomes of this project are broadly applicable to supporting health and well-being.